Substance Abuse Treatment Development and Clinical Research Mentoring

DESCRIPTION (provided by applicant): The overall aim of this K24 Mid-Career Investigator Award in Patient-Oriented Research is to allow Dr. Frances Levin to continue to expand her programmatic line of clinical research and mentoring. Three objectives drive the applicant's work: 1) develops pharmacotherapies that consider the heterogeneity of substance abusers 2) provides mentorship to junior clinical investigators, and 3) contribute service to the field. Primary activities and accomplishments include promoting the recognition and treatment of adult attention- deficit hyperactivity in substance abusers, developing novel combined medication treatment strategies for cocaine and cannabis-dependent individuals, and pursuing promising medications combined with motivational and behavioral treatments for cannabis dependence. During the course of the award Dr. Levin will be PI of 3 RO1s (two are multi-site controlled trials) and PI of a T32 that targets the training of physicians. Additionally, she will continue to serve as the PI of a major R01-equivalent project investigating a combined pharmacotherapy for cannabis dependence and serve as the Director of the Education Core of a long-standing Medications Development Center. Further, she will serve as a Co-PI or Co-I on several other RO1s with both junior and mid-career colleagues that extend her areas of interest. The career development plan for this application will expand Dr. Levin's knowledge into the areas of molecular genetics and neurocognition through accessing the expertise of specialists in these areas. The mentoring plan incorporates trainees at various levels of development: 1) pre-doctoral trainees; 2) post- doctoral trainees (psychiatric residents or substance abuse research fellows); and 3) junior faculty. An overarching career goal has been to train and mentor clinical investigators and advance knowledge in the substance abuse field through synergistic collaborations with other investigators, often with individuals that Dr. Levin has mentored or is currently mentoring. The research and mentoring plan has major public health significance. Substance abuse is often accompanied with additional psychiatric comorbidity and effective treatments for comorbid individuals remain elusive. Moreover, there has been minimal research evaluating pharmacotherapies for cannabis dependence, despite its substantial morbidity. Of great public concern is a dearth of adequately trained physician- investigators interested in clinical substance abuse research careers. Through Dr. Levin's activities it is hoped that the treatment of substance abusers will improve, both through her research and collaborations with colleagues, and through her training of the next generation of clinical investigators.

Public health relevance
PUBLIC HEALTH RELEVANCE: The objectives of this patient-oriented K24 proposal is to gain greater knowledge of novel treatment options for substance use disorders as well as possible vulnerabilities that might place certain populations at risk for substance abuse and impede treatment efficacy. These goals address a critical public health need and will be attained through the applicant's programmatic line of patient-oriented research and her mentorship of trainees, junior faculty, and other mentees such that they obtain the necessary research skills to pursue independent clinical research careers. Project Narrative The objectives of this patient-oriented K24 proposal is to gain greater knowledge of novel treatment options for substance use disorders as well as possible vulnerabilities that might place certain populations at risk for substance abuse and impede treatment efficacy. These goals address a critical public health need and will be attained through the applicant's programmatic line of patient-oriented research and her mentorship of trainees, junior faculty, and other mentees such that they obtain the necessary research skills to pursue independent clinical research careers. __SpecificAimsTextDelimiter__ 4. Research Plan A. Overall Aim Under the K series, I have received funding that has protected my time and allowed me to devote the majority of my time to patient-oriented research and mentoring. The K24 will allow me to continue this trajectory, The overall aim of this K24 program is to keep protecting my time so that I can focus my efforts almost exclusively on the development of my program of research in the field of drug abuse treatment, and mentoring young investigators, particularly physicians, toward careers in patient-oriented research in the addictions. Some of my mentees have worked on my projects to gain "hands-on" experience, and culled existing data sets to publish first-author papers whereas others have collected data with add-on or independent projects to develop their own areas of research. The research plan over the next five years includes participation in a number of ongoing, patient-oriented studies. I am currently the PI on two multi-site collaborative R01s, 1 RO1, and another R01-equivalent major project as part of a Medications Development Center. In addition I am the Co-PI or Co-I on several additional R01s. I have utilized these trials as opportunities to launch or enhance the careers of new investigators and provide the context of future research plans. Of note, all of our trainees in the T32 fellowship gain valuable experience in implementing and conducting clinical trials through their attendance at staff meetings, supervision with me, and carrying out clinical assessments in this and other treatment trials running at our research program.